Optimizing a self-directed mobile mindfulness intervention for improving

As survival has improved for the 2 million people with cardiorespiratory failure managed annually in
US intensive care units (ICUs), it has become apparent that these patients suffer from severe and
persistent post-discharge symptoms of psychological distress including depression, anxiety, and post-
traumatic stress disorder (PTSD). However, few targeted interventions exist that are relevant to
patients' experiences and that accommodate their many physical, social, and financial barriers to
personalized care. To fill this gap, we developed an innovative app-based mobile mindfulness training
program that promotes automated care delivery and self-management of symptom-related distress.
Subsequently, we conducted a pilot randomized clinical trial (RCT) called the LIFT study (R34
AT00819) that compared mobile mindfulness to both a standard telephone mindfulness program and
an ICU education control among survivors of cardiorespiratory failure. We found that mobile
mindfulness was feasibly delivered, acceptable, usable, and had a greater clinical impact on
psychological distress than either comparator. This trial also highlighted opportunities to improve the
intervention's impact related to its targeted population, content delivery, and system technology.
To address these gaps, we propose a 5-year project that is conceptualized as the Optimization
Phase of a multiphase optimization study (MOST) framework. We will optimize mobile mindfulness
with four specific aims: (1) Optimize the usability of key technological elements of mobile mindfulness;
(2) Using a factorial experimental design, identify which intervention components contribute most
meaningfully to feasibility, usability, and impact on psychological distress; (3) Explore barriers and
facilitators to intervention implementation; and (4) Using a mixed methods approach and data from
Aims 2 & 3, refine, update, and operationalize the final mMT intervention system. At the conclusion of
this U01 involving 320 cardiorespiratory failure survivors, we will deliver a mobile mindfulness system
fully optimized for usability, efficiency, scalability, and clinical impact that will be off-the-shelf ready for a
next-step definitive RCT—and can serve as a model for distance-based mind and body interventions.
Innovative elements of our U01 proposal include its paradigm-shifting automated stepped therapy
approach and its easily disseminatable mobile app delivery system—attributes that could allow
seamless, inexpensive population-level scaling of mMT and other mind-body therapies. This study
addresses research priorities on distress symptoms, personalized precision medicine, and self-
management outlined by the National Institutes of Health and numerous professional societies. Our
proven research network has the experience to conduct this U01 project that could advance the field
with a personalizable therapy that fills an important clinical care gap for a growing population.

Public health relevance
Project Narrative Millions of patients experience cardiorespiratory failure requiring treatment in an intensive care unit (ICU) each year. Afterward, they commonly suffer from serious symptoms of depression, anxiety, and post- traumatic stress disorder (PTSD) for months to years--yet have few therapies relevant to their experience. We propose testing an innovative app-based mindfulness training program to see what elements of the program work the best among patients with high levels of distress after arriving home from the hospital. This program has great promise to become a highly scalable therapy for patients' great burden of distress.